Reliability and regional specificity of glutathione and gamma-aminobutyric acid edited magnetic resonance spectroscopy in the human subcortex

PROJECT SUMMARY
A biological test to diagnose, track, and predict Parkinson’s disease (PD) remains elusive.
Development of such a test will aid the detection, treatment, and possible prevention of PD. Novel
applications of neuroimaging technologies for anatomically localized measurements of specific
brain chemicals show promise in meeting this need. Our proposed work will adapt a recently
developed magnetic resonance imaging technique to measure chemicals in deep brain structures
in vivo. This work aims to evaluate the reliability and regional specificity of this technique in healthy
adult humans and will selectively measure chemicals in target brain areas implicated in PD.
Establishing measurement reliability and anatomical specificity is an important prerequisite for the
future use of the protocol in clinical research and will lay the foundation for studies aimed at
developing this approach as a neuroimaging biomarker of PD to aid in clinical diagnosis, disease
tracking, and evaluation of treatment efficacy.
The loss of dopamine in the basal ganglia is a defining feature of PD. However, abnormal
levels of other brain chemicals may precede the loss of dopamine and accelerate PD progression.
These chemicals include glutathione (GSH) and gamma-aminobutyric acid (GABA). GSH is a
naturally occurring antioxidant that protects brain cells from oxidative stress which results from
chemical reactions with unstable oxygen-containing molecules. GSH neutralizes these unstable
molecules. Insufficient levels of GSH hasten dopamine cell loss in animal models of PD and are
also observed in post-mortem deep brain tissue from individuals with PD. GABA is another
naturally occurring chemical and is the principle inhibitory neurotransmitter in the adult human
brain. GABA levels in deep brain structures of individuals with PD correlate with motor symptom
severity. In vivo measurement of GSH and GABA in targeted deep brain regions could have far
reaching impacts by helping to predict whether a person will develop PD, track disease
progression, and assess treatment efficacy.
Single-voxel magnetic resonance spectroscopy (MRS) is a non-invasive imaging method for
quantifying the amounts of specific molecules within targeted anatomical regions of interest. A
specialized MRS sequence was recently developed for the simultaneous measurement of GSH
and GABA in the human brain, but has not been used to study deep brain areas commonly
affected in PD. The proposed work will apply this MRS scan in the substantia nigra and thalamus,
two regions that exhibit abnormal GSH and GABA levels in PD.
Thirty healthy adults will undergo MRS scanning twice, on separate days. At each session,
simultaneous measurements of GSH and GABA will be taken in three regions of interest: 1) the
substantia nigra on both sides of the brain, 2) the left thalamus, and 3) the right thalamus. Each
scanning session will take approximately 60 minutes. Comparisons across days will evaluate
reliability and comparisons between regions will assess regional specificity. The data will provide
benchmarks for future translation of the method to PD clinical trials. Immediate next steps for this
work will focus on the development of the imaging protocol as a diagnostic and preclinical tool.

Public health relevance
PROJECT NARRATIVE Parkinson's disease is associated with abnormal levels of glutathione and gamma-aminobutyric acid in subcortical brain regions. This project will evaluate the reliability and regional specificity of a non-invasive magnetic resonance imaging protocol for measuring glutathione and gamma- aminobutyric acid in these subcortical brain regions in healthy adult humans. This work will set the stage for future investigations in clinical populations.